REPRODUCIBILITY OF US, CT, MR PERFUSION IMAGING OF COLON CANCER XENOGRAFT MODEL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The aim of this study is to compare reproducibility of US, CT, and MR-perfusion imaging in a tumor model (most likely colon cancer xenograft) using Microbubbles (SonoVue), an iodine-based contrast agent (e.g. Isovue), and a gadolinium based contrast agent. After initial training on the ultrasound equipment, this will become a service project, with the investigators running the equipment. The participation of the Center for In Vivo Microscopy is arranging for delivery by Dr. Laurence Hedlund of the mice from Piedmont Research Center (LSW480 colon tumors)